Synergistic microglial activation and tumor cell killing for improved GBM response

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM) is the most common and aggressive primary brain tumor in adults. Current therapies remain
unsuccessful in improving overall survival; thus, the identification of novel therapies for GBM is critical. We have
pioneered a novel, targeted immunotoxin (IT)-based cytotoxic therapy, D2C7-IT, that targets epidermal growth
factor receptor (EGFR) and mutant EGFR variant III (EGFRvIII), established driver oncogenes of GBM. In
preclinical studies, D2C7-IT targets and kills a substantial number of tumor cells and prolongs survival but is
unable to generate cures in all treated animals because of the presence of a highly immunosuppressive GBM
microenvironment. The majority of the immune cells in the GBM microenvironment are tumor-associated
macrophages (TAMs), which promote tumor cell growth and inhibit antitumor T cell responses. Therefore,
eliminating TAM-mediated immunosuppression is anticipated to enhance D2C7-IT-induced antitumor immune
responses. CD40 is an immune co-stimulatory molecule whose activation is known to re-educate TAMs, and
also induce T cell responses. Thus, the central hypothesis driving the present proposal is that overcoming
TAM immunosuppression and tumor-promoting activities via CD40 co-stimulation will improve the
efficacy of the cytotoxic D2C7-IT therapy. Accordingly, our preliminary studies have demonstrated that (1) in
a mouse glioma model, D2C7-IT+αCD40 functions synergistically to prolong survival and generate significant
cures, (2) brain resident microglia is the principal antigen-presenting cells (APCs) activated by the combination
therapy, and (3) αCD40 treatment engages CD8+ effector T cells that are antitumorigenic only when combined
with cytotoxic D2C7-IT. Our results strongly imply that αCD40 alters either the development or activity of TAMs
in GBM and activates microglia/T cells. Demonstrating the antitumor efficacy of the D2C7-IT+αCD40 therapy in
relevant brain tumor models and gaining insights into their mechanism of action will greatly aid in the clinical
translation of D2C7-IT+αCD40 therapy. Therefore, we propose to pursue three Specific Aims to characterize
D2C7-IT+αCD40 antitumor efficacy, TAM re-education, and microglia/T cell activation mechanisms: Aim 1:
Evaluate whether αCD40 overcomes TAM immunosuppression and enhances D2C7-IT efficacy in two preclinical
immunocompetent glioma models. Aim 2: Define whether microglial CD40/MHCII molecules are the mediators
of D2C7-IT+αCD40 antitumor immune response. Aim 3: Determine whether D2C7-IT+αCD40 therapy stimulates
CD8+ effector T cell response capable of eliminating antigen-positive as well as antigen-negative tumors. The
proposed research is significant because it will result in the development of a therapeutic strategy for
simultaneous tumor cell killing, reversal of TAM immunosuppression, activation of microglia and T cells, and
ultimately could be translated and tested in the clinic.

Public health relevance
Public Health Relevance Glioblastoma (GBM) is the most common and aggressive type of brain cancer in adults, and effective treatment for GBM remains an unmet need. Therefore, it is critical to evaluate novel therapeutic approaches that will be beneficial for individuals afflicted with this debilitating disease. To develop protective antitumor immunity and improve GBM patient survival, we propose to simultaneously destroy tumor cells and activate microglia/macrophages, specialized immune cells in the tumor microenvironment. This study should result in the development of a novel therapeutic combination that will improve GBM patient survival.